Examining Mass Media, Mental Health Literacy, and Public Mental Health Stigma Among the Latinx Population Residing in Nontraditional Receiving Communities

Abstract
The Latinx population faces persistent and growing inequities in the access to, utilization, and quality of mental
health care for depression, even after adjusting for health insurance status and socioeconomic factors. Mental
health literacy and public mental health stigma continue to be persistent barriers to mental health services care
in this population. Little is known about the types of media content available to and consumed by Latinx adults
in non-traditional receiving communities and how Spanish-language media news portrays depression. The
present study will address the following three aims: (a) characterize how Latinx adults use different types of
mass media to seek information about depression and depression treatment and examine how social-
demographics, acculturation factors, current depressive symptoms, and past experiences with mental health
treatments are related to mass media use; (2) examine the relationships between mass media use and mental
health literacy and public mental health stigma; and (c) conduct a content analysis of the depictions of
depression in U.S. Spanish-language news sources to examine the presences of stereotypes, recovery
themes, and educational information. Findings from this study will generate new knowledge on the role of mass
media plays in shaping mental health literacy and public mental health stigma and in the Latinx population.

Public health relevance
Project Narrative This proposed study aims to examine mass media use rates, mental health literacy, and public mental health stigma of Latinx adults living in a non-traditional immigrant receiving communities. This study will also identify how depression is covered in U.S. Spanish-language news sources. Findings from this study will inform future mass media interventions that increase mental health literacy and reduce public mental health stigma in the Latinx population.